Protocol Review and Monitoring System

ABSTRACT
The Protocol Review and Monitoring System (PRMS) of the University of Colorado Cancer Center (UCCC) is an
integral component of the clinical research performed at UCCC. PRMS functions for cancer clinical trials across
the UCCC include: 1) review of scientific merit prior to submission to an Institutional Review Board (IRB); 2)
assessment of study priority and feasibility, and 3) monitoring of intervention trials for accrual and scientific
progress. The PRMS collaborates with, but operates independently of, the IRB and the UCCC Data and Safety
Monitoring Committee (DSMC). The PRMS Chair reports directly to the UCCC Director. All clinical cancer
research conducted within UCCC is reviewed to ensure the appropriate PRMS review type occurs and is
captured accurately in the Clinical Trial Management System, OnCore®. New protocol submissions to PRMS
are reviewed at appropriate levels based on the type of review and committee standard operating procedures.
The PRMS is comprised of two committees, the PRMS-Scientific Review Committee (PRMS-SRC) and the
PRMS-Executive Committee (PRMS-EC). Members of these committees reflect the breadth and diversity of
disciplines and programs across the UCCC. The PRMS-SRC meets twice per month to evaluate the scientific
merit of studies and provide a focused, well-documented, and timely scientific review of institutional and industry
intervention protocols. PRMS-SRC membership includes the PRMS Chair, Deputy Chair, biostatisticians and a
diverse group of 30 investigators from oncologic disciplines. In the prior three years, PRMS has reviewed and
prioritized 528 intervention studies. 30% (156) were National Clinical Trial Network (NCTN) or external peer
reviewed studies that received a feasibility and prioritization review only. The remaining 70% were institutional
(89) and industry (283) studies. Of the interventional studies reviewed at full board, 19 of 376 (5%) were
disapproved, 35 of 376 (9%) required modifications be made to the protocol prior to approval, and 75 of 376
protocols (20%) required clarifications prior to approval. PRMS reviews all amendments submitted for active
protocols. The PRMS-EC meets quarterly and assesses the scientific progress of protocols. This group also
creates the by-laws for how PRMS functions and approves all operational changes made to PRMS. PRMS-EC
membership includes the PRMS Chair, Deputy Chair, and six senior investigators. Since July 2016, 36 studies
were closed by PRMS for a lack of progress or closed voluntarily by the principal investigator (PI) following
receipt of low-accrual letters from PRMS. During the next grant period, PRMS will continue to apply a careful
evaluation of feasibility and prioritization to ensure UCCC investigators open studies that are scientifically
meritorious, feasible, and meet the priorities of the UCCC. PRMS will support a continued emphasis on
successful investigator-initiated trials across UCCC. PRMS is working with the Office of Community Outreach
and Engagement (COE) to encourage and promote study inclusion of underserved populations and
underrepresented minorities (URM) and will monitor URM accruals to studies.